Cannabis Regulators Association 2024 Annual Member Meeting: Furthering Regulatory Exchange and Collaboration

PROJECT SUMMARY / ABSTRACT
Cannabis-related policy changes in the US and abroad have outpaced science and research about the impacts
different potential regulatory approaches have on consumer safety, public health, equity, and other outcomes.
Convening regulators from different government jurisdictions to discuss lessons learned and emerging
challenges in cannabis policy and regulation has never been more important. The Cannabis Regulators
Association (CANNRA) is a nonpartisan, nonprofit 501(c)(4) association of government agencies engaged in
cannabis, cannabinoid, and hemp regulation and policy implementation across 45 states and U.S. territories,
Canada, and the Netherlands. The current proposal requests funding to support CANNRA’s 2024 Annual
Member Meeting, a unique event that brings together government officials to discuss different regulatory issues,
share new approaches being taken in their jurisdictions, troubleshoot challenges, and build new skills and
connections to support their ongoing government regulatory work. The meeting is restricted to government
officials only to ensure open sharing and exchange across government jurisdictions. The meeting has two
specific aims: Aim 1 is to improve regulatory science by identifying, discussing, and debating emerging research
and practice-based outcomes in cannabinoid policy and regulation, and Aim 2 is to develop and foster skills that
government regulators can use to implement policies that protect public health and consumer safety. Meeting
content is guided by CANNRA’s Executive Director and PI, Dr. Gillian Schauer, and a Meeting Organizing
Committee comprised of the lead cannabis and/or hemp regulators from seven diverse states (CA, CO, GA, IL,
MD, MO, OK). They work closely with CANNRA Voting Members (key designees from each CANNRA-member
jurisdiction) and co-chairs from CANNRA’s twelve different standing committees to develop and facilitate the
meeting content. Session and workshop moderators are all CANNRA member government officials, and the PI
and Organizing Committee work with moderators to identify panelists who represent diverse perspectives.
Agenda topics are selected using input from past year Member Meeting participants and CANNRA Members
and include skill-based workshops to improve and enhance the skillset regulators can apply to their work. Panel
discussions and workshops are directly relevant to FDA’s mission and the mission of the FDA Office of
Regulation and will cover topics that include: cannabinoid hemp products and policies; cannabinoid product
safety and lab testing; product standards; packaging and labeling regulations; technology and cannabis; data
monitoring; using science to inform policy; public health and youth prevention; and more. CANNRA directly
invites over 900 government staff who participate in CANNRA through our online collaboration platform and
Special Committees. Following the Meeting, CANNRA will disseminate findings and take-aways to government
officials by recording key sessions and making them available to government regulators who cannot attend in
person, and by conducting meeting “report outs” through CANNRA committees.

Public health relevance
PROJECT NARRATIVE Laws legalizing cannabis use for adults have increased exponentially across the U.S. since 2010 with 38 states, the District of Columbia (D.C.), and four U.S. territories legalizing cannabis for medicinal use and 24 of those states, D.C., and three U.S. territories also legalizing cannabis for non-medical (recreational) use. Policy change has outpaced scientific research, and in the absence of federal legalization of cannabis, states have taken different policy approaches, providing a natural experiment that can lend insight into how policies impact consumer safety, public health, and equity. The Cannabis Regulators Association is a nonpartisan association of government agencies regulating cannabis and/or hemp. CANNRA’s 2024 Annual Member Meeting brings together over 200 agency officials and their staff to share emerging practices and develop skills to advance regulatory science.